Research Specialist Support-Targeting DNA Methylation and the Cancer Epigenome

PROJECT SUMMARY / ABSTRACT
Dr. Minmin Liu and the Unit Director, Dr. Peter A. Jones, have worked closely since 2012 and have generated a
significant number of high-quality publications that have had a major impact on the field of cancer epigenetics.
Dr. Liu made the discovery that in cancer cells, treatment with vitamin C or G9Ai (G9A lysine methyltransferase
inhibitor) synergistically enhances the effects of 5-aza-CdR, a DNA methyltransferase inhibitor (DNMTi). The
underlying mechanism is through increased expression of endogenous retroviruses (ERVs) and activation of an
anti-viral interferon response, which inhibits cancer cell growth and causes apoptosis. These findings sparked
her interest in further exploring the roles of repetitive elements (including ERVs) in cancer immune signaling and
in understanding the molecular mechanisms of their expression in cancer cells. Because her studies suggest
that ERVs are important targets of epigenetic therapy, further research in this area is likely to advance the
development of targeted therapies that have improved efficacy in cancer treatment.
The objective of this proposal is to support Dr. Liu's career development as a research specialist in making
significant contributions to Dr. Jones' established research program, which is funded by NCI. Dr. Liu is currently
addressing the following questions. 1) Why are there so many mutations in chromatin modifiers, and what are
the effects of these mutations on the structure of the epigenome? 2) What double-stranded RNAs (such as
ERVs) are activated by 5-aza-CdR and how do these relate to cellular responses? 3) Can we design
combinations of epigenetic drugs that might increase the effectiveness of 5-azanucleoside treatment? The aims
for her future studies are to define the roles of ERVs in cancer immune signaling and to identify regulators for
their expression. These projects will provide new insights for our understanding of the epigenome holistically and
will lead toward novel strategies that increase patient response to epigenetic therapies. This award will enable
Dr. Liu to have the freedom and security to advance her research in cancer epigenetics and to support the
research program of the Jones group.

Public health relevance
PROJECT NARRATIVE This proposal will support Dr. Minmin Liu as a Research Specialist, allowing her to develop a stable and thriving career that will be essential to the research program directed by Dr. Peter A. Jones in the field of cancer epigenetics. Dr. Liu is uniquely suited based on her strong research background, her expertise in second- generation sequencing techniques and computational data analysis for epigenetic/epigenomics studies, and her proven record of significant scientific contributions. Dr. Liu's expertise will generate new insights into the mechanism of epigenetic regulation in cancer and will provide novel approaches to enhancing the efficacy of epigenetic therapies against cancer through the activation of endogenous retroviruses.